Oncogenic Drivers of Rhabdomyosarcoma Cell State, Cancer Stem Cells and Metastasis

Rhabdomyosarcoma (RMS) is the most common pediatric soft tissue sarcoma in the United States. Fusion-
negative (FN) RMS are the most common subtype and are driven by RAS-pathway activation. Despite intensive
treatment with radiation, chemotherapy, and surgery, a large fraction of patients develop refractory, metastatic,
and relapsed RMS that has survival rates of less than 20%. A major hurdle to the design of new and effective
treatments for aggressive RMS can be attributed to our limited understanding of the drivers of cancer stem cell
(CSC) self-renewal and metastasis. The long-term goal and overall objective of our studies is to identify CSCs
and metastatic cells in FN-RMS and then define molecular pathways that can differentiate these cells into non-
proliferative, non-migratory cell types or kill them completely. Our central hypothesis is that FN-RMS CSCs drive
tumor growth, therapy-resistance and metastasis. We also hypothesize that the genes and pathways promoting
the transition of RMS cells into differentiated non-proliferative, non-metastatic cell types can be therapeutically
targeted. The rationale and feasibility of our approach comes from our recent discovery of a novel, molecularly-
defined FN-RMS CSC that expresses mesenchymal pathway-enriched genes and shares remarkable similarity
to a recently discovered bi-potent, muscle mesenchyme progenitor that can make both muscle and osteogenic
cells between 9-14 weeks of human development. This FN-RMS CSC is molecularly-distinct from CSCs reported
by others in the field, can be isolated using CD44/CD90 antibodies and FACs, and expresses genes associated
with epithelial-to-mesenchymal transition (EMT), which is a major driver of metastasis in other cancers. Aim 1
will identify FN-RMS cell heterogeneity and cell types that drive tumor growth and metastasis using single cell
sequencing, lineage and cell fate barcode tracing, and mouse xenograft studies. This work will test the
hypothesis that CD44+/CD90+ FN-RMS cells define the CSCs and that these cells are largely quiescent under
steady state growth conditions, and yet undergo self-renewal divisions following chemo- and radiation-therapy
to drive tumor regrowth and metastasis. Aim 2 will quantify human FN-RMS CSC self-renewal and cell state
transitions in vivo at single cell resolution using fluorescent cell state reporters, photoconvertible cell lineage
tracing tools, and engraftment into optically-clear immune deficient zebrafish. This aim will test the hypothesis
that CSCs undergo asymmetric/symmetric self-renewal divisions following therapy to re-create all the functionally
diverse cell types in RMS. Aim 3 will identify the molecular mechanisms driving FN-RMS cell states, testing the
hypothesis that DNA binding proteins and transcription factors, including NOTCH3 and MEF2C, are dominant
oncogenic drivers of RMS cell fate and independently regulate gene networks that promote CSC and/or
differentiated muscle cell states. This work will have a positive translational impact by defining new pathways to
kill and/or differentiate FN-RMS CSCs and identifying potential biomarkers of therapy resistance based on
retention of CSCs after therapy.

Public health relevance
Cancer stem cells drive continued tumor growth and are likely less responsive to therapy, retained in tumors to cause relapse, and may be responsible for metastatic spread in a subset of cancers. Here, we will identify heterogeneous cell populations that drive these processes in fusion-negative pediatric rhabdomyosarcoma muscle cancer. Our work will also uncover new mechanisms and therapeutic targets that govern rhabdomyosarcoma cancer stem cell self-renewal, cell state changes, and metastasis.